Brown Population Studies and Training Center

OVERALL COMPONENT: PROJECT SUMMARY
The Population Studies and Training Center (PSTC) promotes innovative research on social, institutional, and
environmental dimensions of population structures and processes fundamental to health and well-being.
Established in 1964, the PSTC benefits from a deep, interdisciplinary network of committed scholars at Brown.
This application describes how a new round of dedicated resources for this dynamic community of 62 faculty
associates will advance knowledge within and across social science and public health fields, and leverage
significant university investment for research activity. The PSTC will make distinctive intellectual contributions
in each of five Primary Research Areas: Migration and Urbanization; Children, Families, and Health;
Reproductive Health and HIV/AIDS; Population, Development, and Environment; and Social Foundations of
Health Disparities.

Public health relevance
OVERALL COMPONENT: PROJECT NARRATIVE The proposed award will support infrastructure designed to enhance population science. It will promote innovative research on the social, institutional, and environmental dimensions of population structures and processes that are fundamental to health and well-being.